Role of arginine-vasopressin and V1A receptor in psychosocial stress-induced myocardial injury

PROJECT SUMMARY/ABSTRACT
Heart disease is the leading cause of death in the United States and together with cerebrovascular
diseases account for over 28% of total deaths in the United States. Acute cardiac events (e.g., myocardial
infarction, stress cardiomyopathy, and sudden cardiac death) are concerning because of their unpredictability
and the lack of knowledge regarding causative mechanisms. Psychosocial stressors (e.g., anxiety, personality
traits, social isolation) overburden the cardiovascular system and are risk factors for cardiovascular events and
stroke. Characterization of heart-brain interactions in the context of psychosocial stress is an important first
step in identifying gene-environment interactions that are associated with increased disease risk. Researchers
have proposed that emotional and psychosocial stress may lead to a sympathetic-catecholaminergic surge that
decreases myocyte viability and/or cardiac function. Hypothalamic arginine-vasopressin (AVP) and the V1A
receptor (V1AR) have great therapeutic potential for psychosocial stress-associated heart disease, as AVP
and its receptors promote health and survival by regulating neuroendocrine stress responses. The main thesis
of this proposal is that AVP, acting via the V1AR, promotes health and wellbeing by dynamically modulating
neural responses in the ventral tegmental area (VTA) to stressors. AVP is linked to stress-related disorders in
humans and altered emotional reactivity in animals, that can be modulated by antipsychotic treatment,
suggesting an AVP-VTA interaction in stress-associated responses. However, the neural mechanisms that
underlie the relationships among AVP, Avpr1a gene expression, VTA-dependent stress responses, and
cardiovascular function have not been fully characterized. To address this gap in knowledge, the major goals
of this proposal are to investigate the cardioprotective properties of the neuropeptide AVP and
determine whether there is an association between the Avpr1a gene expression, catecholamine
release, and heart disease outcomes in a psychosocial stress-induced myocardial injury animal model.
Many susceptible individuals are exposed to multiple risk factors that often interact with each other, magnifying
cardiovascular disease risk. Using the Syrian hamster, I plan to investigate the interaction between two
psychosocial risk factors, social isolation and aggression. Aim 1 will test the hypothesis that AVP in the VTA
blocks stress-induced catecholamine release and exacerbation of myocardial ischemia-reperfusion injury, and
aim 2 will test the hypothesis that V1AR gene expression patterns will predict response to stress and AVP-
treatment on heart injury and catecholamines. The trainee will also participate in career development activities:
learn how to perform myocardial ischemia-reperfusion injury surgeries and conduct gene expression studies;
participate in a formal career development program; participate in a special program in cardiovascular genetics
and epidemiology; complete scientific courses to gain new knowledge; improve grant writing skills by receiving
mentorship from experienced investigators; and establish a successful independent research program.

Public health relevance
PROJECT NARRATIVE Exposure to psychosocial stressors is associated with negative health outcomes, including excessive activity of the sympathetic nervous system that may lead to cardiovascular problems. This proposal investigates arginine- vasopressin modulation of the ventral midbrain and responses to psychosocial stressors that are risk factors for developing cardiovascular disease. The proposed study is relevant to public health because it explores the therapeutic potential of arginine-vasopressin, acting via the V1A receptor, in treating psychosocial stress- associated cardiovascular conditions.